Syntheses of homogeneous proteoglycan like glycopeptide and glycoprotein libraries for microarray studies

Proteoglycans (PGs) play important roles in many biological processes including
inflammatory responses, cancer development, immune modulation, and Alzheimer’s disease.
PGs are comprised of heparan sulfate or chondroitin sulfate glycosaminoglycan chains covalently
attached to the core protein through tetrasaccharide linkers. Traditionally, the biological functions
of PGs are believed to be dominated by the glycosaminoglycan chains attached. However, it has
become increasingly appreciated that the core protein can significantly impact glycan activities.
Both the core protein and the GAG chains should be considered to fully understand the PG
functions. To expedite high throughput screening of the binding between PGs and their partners,
the first microarray of PG like glycopeptides/glycoproteins bearing homogeneous glycan
structures is proposed for this project. Due to the heterogeneity of glycan sequences in naturally
existing PGs, it is extremely challenging to purify well-defined structures to study the structure
and activity relationship. Traditional synthetic methods are tedious, which can require over 80
chemical steps to complete a glycopeptide with a glycosaminoglycan chain, severely limiting the
synthetic output. Thus, chemical, chemoenzymatic, and chemoselective ligation strategies will be
developed to break through the synthetic bottleneck and produce PG like
glycopeptides/glycoproteins. These new structures will be incorporated into a PG microarray. The
binding between multiple proteins including growth factors, cell adhesion molecules, amyloid β,
and Tau with the PG microarray will be screened to better understand the key structure features
including the location of GAG chain on the core protein, the number of GAG chain, and the
sulfation patterns of GAG on PG for binding. The binding will be further validated in protein and
cellular studies. The PG microarray can be a powerful new tool to advance our understanding of
the fascinating biological properties of PGs.

Public health relevance
Proteoglycans play important roles in many biological processes such as inflammatory responses, cancer development, immune modulation, and Alzheimer’s disease. In this project, a new microarray technology will be developed, which will contain many proteoglycan-like glycopeptides and glycoproteins bearing homogeneous glycan chains. The availability of this proteoglycan microarray will enable high-throughput screening of proteoglycan binding, and significantly advance the better understanding of the fascinating biological functions of proteoglycans.